Short Term Biomedical Research Training Program for Students

Project Summary/Abstract
The T35 short term research training program at The University of Michigan Medical School,
now in its 37th year, introduces medical students to the concepts of medical research to spawn
the next generation of physician scientists. While the program was previously run in a
summer session between first and second year, a new medical school curriculum has moved
elective research time to the third year. This application proposes to move the T35 supported
training period to this point in the curriculum. The third year medical students entering the
program will have completed preliminary basic science and clinical training and be in an
excellent position to capitalize on this research opportunity. The students will undertake basic,
translational, or clinical research projects under the supervision of 103 faculty preceptors
representing 21 basic science and clinical disciplines. Despite the change in the schedule the
goals of our short term research program are unchanged: (1) Provide students with the
opportunity to learn research concepts and methodologies from active investigators, and
assess their desire to pursue careers in research; (2) Expand the scholarly and research
experiences of medical students as part of an overall career development strategy aimed at
increasing the number of talented students choosing careers as physician scientists; (3)
Promote high quality and intensive research opportunities for those students who are already
on a path toward academic medicine; (4) Provide students who elect not to go into academic
medicine an understanding of the scientific method and critical analysis of literature through
their research experience; (5) Increase the number of students from diverse backgrounds
who participate in a research experience, and ultimately choose careers as physician
scientists; (6) Promote research experiences that can develop into longer-term student-
faculty mentoring relationships; (7) Provide trainees with experience in scientific presentation
and publication of research and (8) Provide students with a high quality didactic program in
research with an emphasis on the ethical and responsible conduct of research. The NIH and
other institutions have recognized the need to increase the number of US physician scientists
and enhance the quality of healthcare and foster clinically relevant innovative research. The
short term research training program at the University of Michigan, with NRSA support, has
a strong record of meeting this need.

Public health relevance
This training program supports short term research opportunities for University of Michigan medical students. The goal of the program is to expose these students to scientific investigation to promote medical research careers and to promote an understanding of the role of medical research in the practice of medicine.